How cell maturation is regulated by circadian and metabolic rhythms

Project Summary/Abstract
The overall goal of my research program is to mechanistically understand how circadian and metabolic rhythms
shape how fully differentiated cells become functionally specialized, or “mature”. Cycles in energy availability,
due to earth’s 24-hour rotation, are the oldest, most consistent environmental input for life on earth. Critical
cellular functions—from gene expression to protein synthesis—are thus optimized to 24-hour rhythms as a key
adaptation to daily life, from bacteria to most cells in our body. How such rhythmic physiology determines maturity
is central to cell and developmental biology, and can be harnessed to build fully functional tissues for regenerative
medicine. In the past decade, chronobiology studies have not only revealed novel insights into mammalian cell
biology, but also identified several uncharted areas with abundant opportunities for further investigation. For the
next five years, we will focus on two such areas: 1) How do circadian and metabolic rhythms determine cell
maturation? 2) How do circadian and metabolic rhythms maintain cell maturity? We will address these questions
in defined human in vitro and mouse in vivo model systems through the following projects: a) using in situ
multimodal mapping of single-cell gene expression and functional states, we will determine how several circadian
clock transcription factors program, synchronize, and entrain maturing cellular activities; b) using in vivo
multiplexed gene editing, we will elucidate the molecular mechanisms by which clock components and feeding
sustain mature tissue chronophysiology. Since chronic misalignment between endogenous and external rhythms
triggers multi-system dysfunction (e.g., metabolic, cardiovascular, and neural syndromes), we believe that
cracking the mechanisms of circadian and metabolic rhythms in the acquisition and maintenance of mature cell
phenotypes will not only reveal critical knowledge to chronobiology, but may also result in actionable insights for
diagnosing and treating disease.

Public health relevance
Project Narrative Circadian and metabolic rhythms play important roles in controlling specialized or “mature” functions in mammalian cells. Here, we will elucidate the molecular mechanisms by which several functionally important circadian clock factors and feeding control maturation and maintenance of specialized chronophysiology in pancreatic islet β and liver hepatocyte cells. Since chrono-disrupted lifestyles fuel multi-system dysfunction, our study will fill critical gaps in our mechanistic understanding of the link between biological rhythms and health, which may offer novel insights for disease diagnosis and treatment.